University of Rochester HIV/AIDS Clinical Trials Unit

The University of Rochester (UR) Clinical Microbiology laboratory is a CLIA-certified laboratory that offers bacteriology (ID and susceptibility), immunology, mycobacteriology, mycology, parasitology, serology, TB and virology testing including specialized antibiotic and antifungal studies. The laboratory evaluates and adds infectious diseases molecular diagnostic tests on an ongoing basis and has sufficient capability for SARS-CoV-2 RNA testing to meet current clinical demands.

Public health relevance
The expanded SARS-CoV-2 testing capacity will assist in identifying people with SARS-CoV-2 infection to assist in medical decisions.